Epidemiology and Pathophysiology of Acute Pancreatitis-related Diabetes Mellitus

Project Summary/Abstract
Acute pancreatitis (AP) is an inflammatory disease that can lead to long-term complications, including diabetes
which is estimated to occur in >25% of patients. Research progress to date has been hindered by limitations
due to study design and case ascertainment for diabetes. The DREAM study, an ongoing, prospective cohort
study with serial assessments of glycemic status, undertaken by the Type 1 Diabetes in Acute Pancreatitis
Consortium (T1DAPC), has been designed to directly investigate the incidence, etiology and pathophysiology
of AP-related diabetes. The Ohio State University Clinical Center (OSU CC), one of the inaugural 10 clinical
centers of the consortium, is a multi-disciplinary team (pancreatology, diabetology, radiology, and nutrition
science) of nationally recognized experts that has worked collaboratively with the other T1DAPC CCs. Over
the past four years, the OSU CC has been actively engaged to develop and contribute leadership to the
T1DAPC organizational infrastructure and has been committed to enrolling and following up participants into
the DREAM study. Overall goals of the current proposal are for OSU CC to continue its servant leadership to
the T1DAPC over the next five years, foster research collaboration, and contribute to studies to understand the
incidence and mechanisms of AP-related diabetes.

Public health relevance
Project Narrative The development of diabetes mellitus following an episode of acute pancreatitis (termed AP-related DM) is now recognized in approximately 25% of patients; however, its epidemiology and pathophysiology remains poorly characterized. The Ohio State University Clinical Center (OSU CC) is interested in joining other Clinical Centers in the Type 1 Diabetes in Acute Pancreatitis Consortium to leverage their collective experience and research infrastructure to address the knowledge gaps in AP-related DM.